Single-Cell Chromatin Mapping Assays

PROJECT SUMMARY
EpiCypher is partnering with Dr. Kami Ahmad to develop scCUTANA™, a first-in-class and widely
accessible single cell (SC) mapping technology for histone post-translational modifications (PTMs). SC analyses
enable the study of rare cell types that are masked when analyzing heterogeneous tissues. Further, SC analysis
allows investigators to reliably cluster and analyze specific cellular subpopulations in situ (i.e. without cell
sorting), which will be key for (pre)clinical applications. Histone PTMs are the focus of many drug development
programs and correlate with unique chromatin features (e.g. promoters, enhancers). Thus, SC analysis of
histone PTMs will provide a powerful new tool to study chromatin structure and gene regulation,
delivering novel insights that are not possible to discern with current SC approaches (e.g. scATAC-seq or scRNA-
seq). Existing mapping assays for histone PTMs, specifically Chromatin ImmunoPrecipitation Sequencing (ChIP-
seq), require thousands of cells to achieve adequate signal over noise (S/N), and thus have poor resolution for
SC analysis. In contrast, our scCUTANA assay platform leverages EpiCypher’s ultra-sensitive Cleavage Under
Targets & Tagmentation (CUT&Tag) technology, which uses antibodies to bind PTMs in situ, and then applies a
protein A-protein G fusion protein to tether hyperactive Tn5 transposase (pAG-Tn5) to these sites. Controlled
activation of Tn5 results in fragmentation and ligation of sequencing adapters for paired-end sequencing. This
ultra-sensitive method can generate high S/N mapping data using as few 1-3 million reads. Dr. Ahmad (with Dr.
Steven Henikoff) has recently developed CUT&Tag-based methods for SC chromatin mapping using nanowell
array- and droplet-based systems. However, these nascent approaches require significant instrument
investments, large sample inputs (>100K cells), and/or are not readily amenable to workflow automation, limiting
their widespread commercial utility and potential clinical application. The innovation of scCUTANA lies within
1) the development of a combinatorial cellular indexing approach that mitigates the need for expensive
instruments / reagents and streamlines sample processing, 2) the ability to scale while requiring minimal cellular
inputs, and 3) the use of DNA-barcoded recombinant nucleosomes to identify specific and ultra-efficient “SC-
grade” antibodies that dramatically increase assay sensitivity and reliability. In Phase II, we will continue
development of this “benchtop” SC genomic mapping technology, by scaling manufacturing of our pAG-Tn5
library (Aim 1), optimizing robust protocols using a range of cells and tissues (Aim 2), and developing automated
workflows and scCUTANA beta kits for internal / external validation (Aim 3). The commercial scCUTANA product
will comprise two 96-well plates, containing 96 uniquely barcoded pAG-Tn5 complexes (Plate 1), barcoded PCR
oligos for library enrichment (Plate 2), and other reagents for sample processing. This disruptive assay platform
will be economical for laboratories of all resources, providing immediate, wide access to SC genomic mapping
of histone PTMs.

Public health relevance
PROJECT NARRATIVE Single cell (SC) technologies enable the investigation of rare cell populations from complex tissues, such as tumors. While some epigenomics methods have been successfully translated to SC resolution, there is no widely accessible SC method to analyze histone post-translational modifications (PTMs), which play diverse roles in gene regulation and disease. Here, we will develop scCUTANA™, a first-in-class “benchtop” SC assay platform for mapping histone PTMs, which will accelerate chromatin research and epigenetics-focused drug development.